Physician Scientist Training in Cancer Research

Summary
With this competitive renewal application, we are seeking five years of support for a Training Program with
the new Title of “Physician Scientist Training in Cancer Research” that has been continually funded since
1975. Since that time, more than 600 physicians and physician-scientists who were part of fellowship training
programs in medical oncology received, through this funding mechanism, the essential support and protected
time that they required to launch an academic career. Of the 117 trainees who have been supported by this
T32 Award during the past 15 years, 13 continue as post-doctoral fellows in training. Of the remaining 104, 10
have left academia to pursue leadership positions in industry focused on cancer medicine, 6 are clinicians at
major medical centers, 2 hold positions at the National Cancer Institute, and the remaining 86 are in academic
positions including 2 Professors, 22 Associate Professors, 39 Assistant Professors, and 23 Instructors.
Excluding fellows still in training, 90 former trainees of the remaining 104 have received external funding for
their research including 37 that have been awarded an individual NIH K-type award. With the present
application, we seek to continue this tradition of training the leaders in academic oncology.
The future of cancer research will continue to depend on the continued training of highly-talented and
creative physician-scientists who possess an understanding of the clinical aspects of neoplastic disease, are
able to apply these concepts to appropriate laboratory studies within the many areas of tumor biology and
emerge as academic leaders with sufficient skills to direct research programs, patient care, and educational
efforts. The development of such individuals can only be accomplished within an environment where
physicians and scientists work in physically adjacent areas, exchanging ideas and collaborating on a wide
array of endeavors. The program will build on a foundation of excellence in Medical Oncology established
during clinical training in the Dana-Farber/Massachusetts General Brigham Medical Oncology Fellowship
Program. All of these candidates have already received an MD or MD/PhD degree, completed 2 or 3 years of
Internal Medicine residency, and at least one year of clinical training in Medical Oncology.
The training grant program will select the most highly qualified candidates from this pool who wish to
pursue laboratory research or clinical investigation at the Dana-Farber Cancer Institute or nearby surrounding
institutions. The program will provide outstanding mentored laboratory and clinical investigation research
experiences from senior and experienced junior faculty and support for the recruitment and mentorship of
under-represented minority fellows. It is expected that at the conclusion of their training, those individuals
supported by this training program will have the ability to design, initiate, and complete individual clinical or
laboratory research projects, will be able to function independently or with minimal supervision, and will be
positioned to soon establish themselves as independent research investigators.

Public health relevance
Narrative The overall objective of this Training Program is to prepare the next generation of leaders in Medical Oncology in laboratory and clinical translational sciences. The program will provide outstanding mentored laboratory and clinical investigation research experiences from senior and experienced junior faculty and support for the recruitment and mentorship of under-represented minority fellows. It is expected that at the conclusion of their training, individuals supported by this training program will have the ability to design, initiate, and complete individual clinical or laboratory research projects, will be able to function independently or with minimal supervision, and will be positioned to soon establish themselves as independent research investigators.